MITAGS SAFETY & FIRE TRAINING FOR COMMERCIAL FISHING FLEET

MITAGS proposes to provide the PNW commercial fishing fleet with USCG approved courses and
team training at and take the lessons learned back to their fleets. The courses are Firefighting
Team Trainer, Basic Training, Medical Person in Charge and Advanced Firefighting.

Public health relevance
MITAGS proposes to provide the PNW commercial fishing fleet with USCG approved courses and team training. Our objective is to train these mariners to take the lessons learned back to their fleets. The courses are Firefighting Team Trainer, Basic Training, Medical Person in Charge and Advanced Firefighting. All MITAGS instructors are USCG approved.